ARISe Coordinating and Collaborating Centers for the Study of Vaccine Hesitancy and Uptake (CDC SIP 12)

Building on a robust, multi-sector partnership between the City University of New York (CUNY) School of
Public Health, the NYU Grossman School of Medicine’s Department of Population Health, the proposed project
aims to increase scholarly understanding of vaccine hesitancy and provide federally-qualified health centers
with managerial and ethical guidance on how increase routine vaccine uptake among children 0-2yrs. Over the
five year project period, NYUGSoM will lead on two research projects: one, a mixed-methods exploration of
vaccine attitudes and beliefs among parents 0-2 years and a second, a managerial and ethical analysis of an
evidence based practice for increasing pediatrics vaccination at a federally qualified health center. Throughout
the project period, CUNY will lead activities to coordinate between the funded Collaborating sites and
disseminate past and new findings through a robust partner network. The first piece of research gathers
individual-level data about the roots of vaccine hesitancy and skepticism among parents of young children, and
critically, how these attitudes have been overcome by individuals who subsequently vaccinated 0-2yr old
children. We will design and field an online survey of parents of 0-2 years, recruiting participants via social
media. The survey will be designed to assess the quality of parents’ relationship to health care providers and
test the acceptability of various behavioral economics approaches to increasing vaccine uptake. The survey
will also act as a recruitment device for follow-up interviews among select participants who report having once
been vaccine hesitant or skeptical but now have children who are up to date on all vaccines. These interviews
will generate data for analysis on how vaccine hesitancy and skepticism has been overcome. The second
piece of research focuses on organizational-level efforts to increase vaccine uptake among 0-2 year olds,
specifically in a federally qualified health center. Informed by behavioral economics and prior literature
indicating effectiveness, a local FQHC adopted an “opt-out” approach to pediatric vaccination where parents
are assumed to consent to vaccination unless they specifically object. Guided by implementation science
frameworks, we will collect data on-site about how this “opt-out” approach is managed to create clear guidance
for other FQHCs nationally that may want to adopt, or adapt a similar approach. Informed by staff perspectives
as well as the previously mentioned parent survey, we will also generate a set of ethical considerations for
using an “opt-out” approach to vaccination in an FQHC population which is often facing various sources of
marginalization and disempowerment. The proposed project is closely aligned with at least four Healthy People
2020 Objectives: (1) to maintain the elimination of measles, rubella, congenital rubella syndrome and polio, (2)
reduce proportion of children who get no recommended vaccinations by 2 yrs of age, (3) maintain the
vaccination coverage level of 1 dose of the MMR vaccine in children by 2 years and (4) increase the coverage
level of 4 doses of DTaP vaccine by 2 yrs of age.

Public health relevance
Project Narrative The NYUGSOM-CUNY Prevention Research Center is responding the two-part call for Collaborating and Coordinating Centers in SIP-24-012 Advancing Research in Immunization Services Network. The enclosed proposal aims to (1) provide novel insight on how parents of young children who once held vaccine hesitant or skeptical attitudes come to vaccinate their children in accordance with CDC guidelines, (2) outline a step-by- step, managerial process for federally-qualified health centers to adopt an evidence-based, “opt-out” approach to childhood vaccinations and offers ethical considerations for prospective adopters and (3) builds a coordinating center that can not only facilitate and synthesize between CDC-funded projects but also network with an array of additional related partners.